A Phase 3 Study of Emixustat Hydrochloride for Stargardt Disease IND 101,084 (02/11/2019)

Project Summary
Stargardt disease (STGD) is a rare, inherited, degenerative disease of the retina, reducing visual acuity to 20/200 or worse
beginning in the first 3 decades of life. Calculated estimates indicate STGD affects roughly 41,119 patients in the US,
making it the most common hereditary macular dystrophy. There are currently no approved treatments for STGD
anywhere worldwide. STGD is characterized by an excessive build-up of lipofuscin at the level of the retinal pigment
epithelium (RPE). The visual cycle isomerohydrolase, RPE65, plays a key role in this chemical pathway. Inhibition of
RPE65 reduces accumulation of lipofuscin and its component bisretinoids; hence, it may slow the progression of STGD.
Acucela, Inc. (Acucela) has developed emixustat hydrochloride (emixustat), an orally administered inhibitor that targets
RPE65. Acucela is now conducting the SeaSTAR study, a phase 3 multicenter, randomized, double-masked study to
compare the efficacy and safety of emixustat with placebo for the treatment of macular atrophy secondary to STGD. The
hypothesis is that emixustat slows the progression of STGD by reducing retinal pathology caused by the accumulation of
lipofuscin. The data obtained in the proposed study will significantly advance the STGD field in two ways. If emixustat
demonstrates efficacy by reducing the rate of disease progression, it would present a major step forward in developing the
first available treatment for STGD patients. Additionally, the SeaSTAR study will contribute substantially to the
understanding of the natural history of STGD due to the large number of patients on placebo. The most significant
obstacle in the field of inherited retinal diseases such as STGD has been an inadequate understanding of the natural
history of these diseases. While recent advances have provided important data on certain aspects of the natural history of
the disease, information in particular on additional functional and structural endpoints as well as quality-of-life measures
is still lacking. The SeaSTAR study will gather data on these measures to fill this knowledge gap. Confirming the
hypothesis that emixustat reduces the accumulation of lipofuscin would provide invaluable proof-of-concept that RPE65
is a valid therapeutic target for further drug development. Additionally, both the US and European governmental drug
approval agencies have agreed that positive results will be evidence of safety and efficacy that can be used for marketing
approval of emixustat as the first approved treatment available for STGD. The primary efficacy endpoint will be the mean
rate of change in mm2/year from baseline in the total area of macular atrophy lesion(s) in the study eye. Secondary
endpoints include, among several, safety and tolerability evaluations, mean change from baseline in retinal sensitivity, and
quality-of-life measurements such as the Functional Reading Independence Index. Exploratory endpoints are mean change
from baseline in extent of abnormal near-infrared fundus autofluorescence and the relationship between pharmacokinetic
exposure of emixustat and efficacy response. In summary, the results of this study will at minimum expand the field of
knowledge of the natural history of STGD and if fully successful provide the first evidence of a treatment effect in this
debilitating, blinding disease.

Public health relevance
Project Narrative Stargardt disease (STGD) is a rare, inherited, degenerative disease of the retina, reducing visual acuity to 20/200 or worse beginning in the first 3 decades of life and affecting roughly 41,119 patients in the US, with currently no approved treatments for STGD anywhere worldwide. Acucela Inc. (Acucela) has developed emixustat hydrochloride (emixustat) and is now conducting the SeaSTAR study to determine if emixustat safely and efficaciously slows the progression of STGD. The results of this study will at minimum expand the field of knowledge of the natural history of STGD and if fully successful provide the first evidence of a treatment effect in this debilitating, blinding disease.